Ultrafast Magic-Angle Spinning Probe for 1H Detection Solid-State NMR to Advance Structural Analysis of Macromolecular Assemblies

PROJECT SUMMARY
Support is requested for the acquisition of a 0.7 mm ultrafast magic-angle spinning (MAS) probe, which will be
installed on an 800 MHz Bruker Neo NMR spectrometer situated in the Max T. Roger facility at Michigan State
University (MSU). The facility, home to 12 NMR spectrometers, has recently undergone significant upgrades and
renovations through MSU's institutional commitment. MSU also sustains two full-time staff scientists for facility
operation and management, along with a helium-recovery system for sustainable operation. The proposed probe
will deliver cutting-edge capability of ultrafast MAS up to 111 kHz, enabling a comprehensive suite of two- and
three-dimensional correlation experiments with 1H detection. The significant enhancement in resolution and
sensitivity will facilitate high-resolution characterization of fully protonated and native cellular samples,
significantly reduce experimental time, enable examination of samples with limited quantities, and foster method
development specifically tailored for carbohydrate-based biopolymers and biomaterials—an area currently
under-investigated yet in need of technical advancements. The instrument will serve eight MSU investigators
from five departments and five external users from esteemed institutions such as Boston Children's Hospital and
Harvard Medical School, Vanderbilt University, Louisiana State University Health Science Center, University of
Maryland, Baltimore County, and Binghamton University. Its utilization will enable in-depth exploration of various
biologically and biomedically significant systems, including the cell wall structure of pathogenic fungal and
bacterial species, their roles in antimicrobial resistance and adaptive survival, the structure-function relationship
of fusion peptides, amyloids, enzymes, and lipids, as well as vaccine and drug development. Being the sole
instrument of its kind in the state of Michigan, it will provide essential services to users regionally and nationally.

Public health relevance
PROJECT NARRATIVE Michigan State University requests the acquisition of a 0.7 mm ultrafast magic-angle spinning solid-state NMR probe for installation on an 800 MHz NMR spectrometer housed in the Max T. Roger NMR facility. This instrument, the only one of its kind in Michigan, will enable 1H detection of fully protonated samples, including cellular and heterogeneous biosystems, and facilitate the analysis of limited quantity samples. These capabilities are crucial for advancing our understanding of biochemically and biomedically significant macromolecular systems, including polysaccharides, membrane proteins, enzymes, amyloids, and cellular systems such as fungi, bacteria, and biofilms, as well as for vaccine and drug discovery research.